ELSIhub/ Center for ELSI Resources and Analysis (CERA) Accessibility Upgrades

Project Summary/Abstract
The Center for ELSI Resources and Analysis (CERA) provides the ELSIhub
platform to enhance the production, sharing, and use of scholarship and resources
focused on the ethical, legal, and social implications (ELSI) of genetics and genomics
and builds the community of stakeholders with an interest in ELSI research. The
proposed implementation of a suite of accessibility upgrades will increase the overall
impact of the center by facilitating the full participation of stakeholders with mobility,
cognitive, hearing, and visual disabilities. CERA has already taken steps to establish a
diverse and inclusive environment by proactively seeking and responding to input from
groups traditionally underrepresented in research. To extend our current efforts, this
request for supplemental funding is undertaken to: 1) advance the accessibility level of
the ELSIhub online platform so that it is in conformance with established criteria at the
highest possible international standard, 2) enhance broad participation in CERA
convenings and use of archived resources by attending to the communication
modalities of all stakeholders, and 3) catalyze uptake of accessibility measures by
others in the genomics community by modeling accessibility practices and sharing
downloadable resources.

Public health relevance
Project Narrative The CERA mission is to enhance the production, sharing, and use of scholarship and resources focused on the ELSI of genetics and genomics and build the community of stakeholders with an interest in ELSI research. The inclusion of stakeholders from a broad range of disciplines, professional backgrounds, career stages, and lived experiences is central to the achievement of this mission. This proposal seeks to upgrade the accessibility of the ELSIhub platform, convenings, and resources for those with mobility, cognitive, hearing, and visual disabilities.